Spatiotemporal Regulation of GPCR Signaling by Different Beta-Arrestin Conformations

G protein-coupled receptors (GPCRs) at the cell surface regulate most physiological processes and are
important drug targets with ~34% of all prescribed drugs targeting them. Classically, upon agonist stimulation,
GPCRs activate heterotrimeric G proteins, causing downstream signaling throughout the cell. In order to
terminate G protein signaling, cells have devised a specialized desensitization mechanism that includes receptor
phosphorylation by GPCR kinases and subsequent recruitment of β-arrestins (βarrs) to the phosphorylated
receptors. The GPCR–βarrs interaction both blocks the G protein-binding site at the receptor core and promotes
receptor endocytosis. Recently, however, we discovered that some GPCRs interact with βarrs exclusively
through their phosphorylated C-terminal tails. Since βarrs do not block the G protein-binding site in this `tail'
conformation, the receptor can associate with βarrs and G proteins simultaneously to form GPCR–G protein–
βarr `megaplexes.' The assembly of these megaplexes allows the receptor to continue to stimulate G protein
signaling while being internalized into endosomes by βarrs. Thus, the existence of the core and tail GPCR–βarr
complex conformations suggests that βarrs act as spatiotemporal master regulators of G protein signaling: When
bound to the receptor core, βarrs regulate the duration of G protein signaling whereas βarrs control the cellular
location from where G proteins are activated from when associated with the receptor C-terminal tail. As the
underlying properties that promote these two complex conformations remain elusive, my research objectives
over the next 5 years involve determining these molecular driving forces on a general scale. Our preliminary data
suggest that phosphorylation site clusters located within the receptor C-terminal tail are required for the
association with βarrs in the tail conformation. Therefore, we plan to establish whether the presence of these
phosphorylation site clusters correlates with the capacity of GPCRs to engage in mechanisms that lead to
sustained endosomal G protein signaling. In regards to the GPCR–βarr core conformation, the fingerloop domain
(FLD) of βarrs inserts itself into the transmembrane core of most GPCRs via its hydrophobic tip and receptor-
specific residues. To characterize this interaction on a general scale, we will examine whether these receptor-
specific βarr-FLD residues correlate with G protein subtype coupling of different GPCRs. Finally, βarrs modulate
the activity of phosphodiesterases (PDEs), which terminate Gs-cAMP signaling. However, our preliminary data
raise the possibility that this modulation occurs specifically by βarrs in the core conformation. Therefore, we will
apply a combination of cell biological, biochemical, and proteomics approaches to examine whether modulation
of PDEs and other desensitization mechanism is mediated specifically by distinct βarr conformations. My vision
with this research program is to elucidate how GPCR signaling is regulated spatiotemporally by βarrs, which
may lead to differentiated physiological responses. The knowledge acquired here will be used to design new and
innovative therapeutics that specifically target GPCRs in time and space.

Public health relevance
In general, GPCRs activate G protein signaling at the cell surface, which is followed by rapid signal desensitization and receptor internalization by -arrestins. However, recent studies suggest that some receptors continue to stimulate G proteins after they have been internalized into endosomes by -arrestins in an unappreciated conformation. As endosomal G protein signaling is associated with unique physiological functions, this project seeks to understand the underlying receptor/-arrestin properties that drive this mechanism, which can be leveraged for future drug development efforts.